Development of an HIV infection model of human foreskin to obtain novel insights into virus transmission

Project Summary/Abstract
Understanding the mechanisms involved in HIV acquisition and transmission is critical for novel prevention
strategies. The understanding of early events in HIV-1 acquisition and expansion of the virus remains
incomplete, especially in males. The incidence of sexually transmitted infections (STI’s) can increase HIV-1
acquisition risk, and there exist gaps in understanding the mechanisms also. This study will exploit the
medical male circumcision (MMC) roll out in South Africa, which facilitates the collection of otherwise
discarded foreskins to characterize male genital tissue-resident HIV-1 target cells. Dr Chigorimbo-Tsikiwa
will characterize the molecular and functional interactions between HIV-1 , lymphoid and myeloid target cells
from the FS. A uniqueness of the proposed study lies in interrogating how in vivo activating events from
bacterial STIs can modulate ex vivo HIV-1 target cell susceptibility. We hypothesize that foreskin tissue
contains several cell lineages that are susceptible to HIV-1 infection that can support viral expansion and
that the increased inflammatory response induced by asymptomatic STIs will exacerbate this susceptibility.
Aim 1 will investigate the phenotypic and transcriptomic profiles between lymphoid and myeloid cells
isolated from the foreskin tissues from men with and without asymptomatic bacterial STIs. Aim 2, will
determine the impact of immune activation on the susceptibility of lymphoid and myeloid cells to HIV-1
infection. Dr Chigorimbo-Tsikiwa will challenge foreskin-derived cells with a panel of HIV-1 isolates to
assess the relative susceptibility of characterized cells to HIV-1 infection. We will explore the impact of in
vivo immune activation by performing HIV-1 challenge on cells isolated from STI-positive individuals as well
as to in vitro activation using Chlamydia antigens, LPS and TLR agonists on viral infectivity and expansion.
Interferon stimulated genes, (ISG’s) antagonists have been shown to confer an antiviral state in cells and
against other retroviruses. Therefore, aim 3 will assess the repurposing of bis-arylidenecycloalkanones as
ISG agonist for use as anti -HIV-1 molecules in various cell models. This research study based from human
foreskins will provide novel insights in HIV acquisition and transmission in the male genital tract and
increase knowledge in the field which will facilitate the research career development of Dr Chigorimbo-
Tsikiwa. Dr Chigorimbo-Tsikiwa will receive mentorship from lead researchers who are prolific publishers,
possess several research grants in infectious disease biomedical research who have mentored
approximately 40 post-docs between them in Dr David Russell at Cornell University, Dr Frank Kirchhoff at
Ulm University in Germany and Dr Clive Gray in South Africa. This study will allow Dr Chigorimbo-Tsikiwa
access to high technology driven research in three continents afforded by her mentorship relationships
during this K award spring boarding her as an independent African HIV biomedical scientist.

Public health relevance
Project Narrative This proposal will establish which HIV immune target cell populations found in the human foreskin can be infected with HIV-1. The objective is to identify molecular pathways and activation signals that determine this susceptibility and whether a male with an asymptomatic sexually transmitted infection has enhanced susceptibility. Repurposing interferon agonists will be assessed for activity as anti-virals in human foreskin and other cells.